Probing the Influence of Oxygen Toxicity on Tau Hyperphosphorylation caused by Mitochondrial Dysfunction

Project Summary / Abstract
Most mortality-causing diseases of aging, including Alzheimer’s disease and its related dementias
(ADRDs), cancer, and heart disease, are exacerbated by aberrant mitochondrial function. Mitochondrial
dysfunction is one of the earliest known features of ADRDs such as frontotemporal lobar degeneration (FTLD).
Yet its multivariate roles in causing the molecular chain of events that lead to neurodegeneration and cognitive
decline remain unknown. Increasing evidence demonstrates there is significant commonality and overlap in the
pathophysiology of mitochondrial failure in aging-related disorders and mitochondrial disease using a leading
mammalian model missing the electron transport chain protein NDUFS4. These mice exhibit severe
neurodegeneration, weight loss, and premature death. Decreased activity of the electron transport chain, which
is similarly observed in ADRD patients, is hypothesized to promote the build-up of oxygen in the brain causing
oxidative damage, neuroinflammation, and neuronal cell death. Chronically housing these mitochondrial disease
mice at reduced oxygen concentrations remarkably extends lifespan 10-fold, prevents loss of weight and body
fat, prevents astrogliosis, microglial activation, neuroinflammation, brain lesions, and the disease phenotypes.
Follow-up experiments indicate NDUFS4-KO mice have ~3-fold increases in tau phosphorylation at
known pathogenic sites and hippocampal tau aggregation. Tau is a microtubule binding protein that stabilizes its
assembly for proper physiology, however, excess tau phosphorylation destabilizes microtubules and forms
proteotoxic aggregates that are common features of tau pathology. Housing mitochondrial disease mice in low
O2 chambers prevents aberrant tau, Gsk3β, and TTBK2 phosphorylation amongst other changes. This data
clearly reveals that mitochondrial dysfunction elicits tau hyperphosphorylation, and suggests aberrant O2 status
may be a driving factor. Furthermore, hypoxic regimens prevent tau hyperphosphorylation and double lifespan
in transgenic nematodes expressing human tau. The proposed work will provide critical insights into the
mechanistic underpinnings of oxygen-induced tau hyperphosphorylation caused by mitochondrial dysfunction
taking a hypothesis driven approach based on preliminary data and literature precedent. It will characterize tau
pathology and illuminate the role of tau kinase Gsk3β in mitochondrial disease. It will also probe changes in
interorganellar communication caused by mitochondrial dysfunction and O2-induced toxicity via NADPH
oxidases. Finally, this proposal will explore the influence of mitochondrial dysfunction and oxygen toxicity in well-
established mammalian tauopathies, and the capacity for low oxygen interventions to prevent the onset of tau
pathology. Collectively, these complementary hypothesis-driven basic science studies will provide a better
understanding of mitochondrial biology and illuminate the mechanistic role of signaling pathways in regulating
tau phosphorylation in mitochondrial disease. The achievement of these aims may even have broader
implications in the prevention of other diseases of normative aging such as ADRDs, heart disease, and cancer.

Public health relevance
Project Narrative Mitochondrial dysfunction is increasingly associated with many currently incurable late-onset diseases such as Alzheimer’s disease, heart disease, and cancer. Preliminary results suggest that mitochondrial dysfunction causes molecular oxygen-mediated tau hyperphosphorylation, aggregation, and proteotoxicity – which is thought to be a leading cause of Frontotemporal Lobar Degeneration, Alzheimer’s Disease, and other tauopathies. This proposal aims to mechanistically understand these phenomenological results and stands to enable the rational pursuit of innovative approaches to prevent tauopathies.